Hawaii IDeA Center for Pediatric and Adolescent Clinical Trials 2 (HIPACT 2)

ABSTRACT
The principal objective of this second cycle of Hawaii IDeA Center for Pediatric and Adolescent Clinical Trials2
(HIPACT2) is to capitalize on the success of the first fouryears of HIPACT as a productive and engaged
Environmental Influences of Child Health Outcomes IDeA States Pediatric Clinical Trials Network (ECHO
ISPCTN) site. The first four years of HIPACT launched ECHO ISPCTN clinical trials, engaged new junior
investigators in ECHO ISPCTN endeavors and built pediatric clinical trials capacity at HIPACT's partner
institutions. As a relatively small ECHO ISPCTN site with a historical paucity of pediatric involvement in clinical
trials, HIPACT successfully inspired and engaged new junior faculty across the spectrum of professional
development activities. The initial success of HIPACT spirited the momentum for academic and community
efforts to participate fully in the planning of HIPACT2 including newly committed partners. We have established
a mechanism to participate in HIPACT2 by engaging pediatric and maternal-fetal medicine faculty through the
Hawaii Pediatric Research (HIPR) Scholars Program. Moreover, we will endeavor to feed into the pipeline of
ECHO ISPCTN activities with the goal of increasing the number of junior faculty involved in HIPACT2. With the
overarching goal to improve the health and wellbeing of the diverse multiethnicpopulations in rural and
underserved areas of Hawaii including indigenous Hawaiian communities, and immigrant populations of Pacific
Islanders and Asians, HIPACT2will capitalize on established HIPACT partnerships with Hawaii Pacific Health
(HPH) Kapiolani Medical Center for Women and Children (KMCWC), and Waianae Coast Comprehensive Health
Center (WCCHC). The following Specific Aims are proposed: Aim 1: To actively contribute to and participate in
ECHO ISPCTN pediatric clinical trials; Aim 2: To provide access to clinical trials to benefit rural and underserved
infants, children, and adolescents, many of who are Native Hawaiians, Pacific Islanders, and Asians; Aim 3: To
participate in the “science” of ECHO ISPCTN multicenter clinical trials research; Aim 4: To mentor a cadre of
junior faculty via the Hawaii Pediatric Research (HIPR) Scholars Program. Taken together, HIPACT2 will act as
an eager partner in ECHO ISPCTN in this second five-year cycle of funding with a strong historical track record
of engagement and achievement, institutional support, and newly committed partners. It will enrich opportunities
for faculty research training and education, participation in collaborative multicenter clinical trial research, and
engage rural and underserved communities to improve health outcomes in Hawaii and across the nation.

Public health relevance
NARRATIVE The Hawaii IDeA Center for Pediatric and Adolescent Clinical Trials2 (HIPACT2) will build upon the success of the first cycle of HIPACT as a continuing partner in the Environmental Influences on Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials Network (ISPCTN). In this second five-year cycle of funding, with an engaged pediatric clinical faculty, newly committed partners and generous institutional support, HIPACT2 will increase opportunities for faculty development, participate in collaborative multicenter clinical trial research, and engage rural and underserved communities to improve health outcomes in Hawaii and across the nation.